The Chemistry and Biology of Protein Glycation

Project Summary
Glycation is a non-enzymatic posttranslational modification (PTM) that occurs through the spontaneous
reaction of reducing sugars or sugar metabolites with amino and guanidino groups on proteins. Glycation is a
hallmark of many diseases, including diabetes, cardiovascular disease, cancer, Alzheimer's disease, and age-
related macular degeneration. However, compared to enzymatic PTMs, the biological role of glycation remains
poorly understood. This is because traditional biochemical and chemical biology tools, which inhibit or profile
specific enzyme activities, are not well-suited for the study of a PTM that transpires without an enzyme. As a
result, new methods that can overcome the challenge of non-enzymatic, spontaneous, chemistry in living cells
are critically needed. The overall objectives of this project are to develop chemical methods that can precisely
control the glycation of ubiquitin, and to use these to study the functional consequence of glycation on ubiquitin-
driven protein degradation. Our specific aims are to (1) identify features of protein sequence that promote
glycation outcomes (2) identify features of protein structure that influence glycation outcomes, and (3) determine
the impact of glycation on ubiquitin-driven proteolysis.
Our central premise is that selective glycation is templated by the combination of sequence and structure that
surrounds a reactive site. In support of this premise, our preliminary and published data show that primary
sequence can govern both overall glycation levels and specific product distributions, while protein structure
sculpts the specific glycation products that form. In our first aim, we examine the contributions of sequence using
combinatorial peptide libraries to vary primary sequence and examine the effect on glycation type and extent for
each of the four glycated sites we have identified in ubiquitin. These experiments will identify sequences that
promote varying extents of total glycation and/or bias the formation of specific glycation products. In our second
aim, we describe experiments to further define how structure contributes to glycation outcomes using a series of
point mutations that disrupt structure or alter the chemical microenvironment within ubiquitin. We also integrate
these data with computational models that will be used to predict glycation sites. Finally, we will use this
information to define and validate a series of “dialAGE” ubiquitin variants that can predictably modulate glycation
outcomes in living cells by altering susceptibility to glycation, and/or by promoting the formation of specific
glycation adducts. In our third aim, we use these tools to uncover the mechanism through which glycation
prevents protein degradation by the ubiquitin-proteasome system in living cells. Specifically, we will test the
hypothesis that the glycation of ubiquitin itself impairs protein degradation. This work will therefore provide long-
sought methods that can explore the functional role of glycation, and will reveal new therapeutic targets for a
range of diseases. These studies will dramatically improve our understanding of glycation and will have an
immediate impact on our appreciation for how this unique PTM influences human health, aging, and disease.

Public health relevance
Project Narrative Glycation is a spontaneous protein modification that is correlated with many diseases, including cancer, diabetes, Alzheimer’s disease, and age-related disorders. The proposed work will lead to important breakthroughs in our understanding of how glycation is templated, which will enable studies of the functional consequences of glycation. Establishing the biological cause and effect of glycation will have an immediate impact on our understanding of the exact role of glycation in aging and disease, and will provide access to new targets for their prevention or treatment.